Tumor Plasticity

PROJECT SUMMARY
Despite half a century of social and economic investments, an unprecedented understanding of cancer genes
and their pathways, and an arsenal of new molecular and immunological therapies, a diagnosis of malignancy
still carries significant morbidity and mortality. Heralded as a breakthrough for cancer “cures”, the promise of
personalized medicine, where every patient receives the right drug for the right type of cancer based on
genetic makeup is yet to be realized. In fact, most molecularly-­targeted drugs have been disappointing in the
clinic, producing only short-­lived responses, often at staggering costs and financial hardship for the patients,
only to be supplanted by the emergence of drug-­resistant and metastatic disease. We know that the
extraordinary heterogeneity of human tumors, with hundreds of malignant clones in constant competition and
cooperation with each other, is a major reason for treatment failure, but an in-­depth understanding of this
process has remained surprisingly elusive. Work carried out by our group over the past ten years has focused
on mechanisms of tumor adaptation, or plasticity as novel, fundamental drivers of disease heterogeneity and
worse patient outcome. We found that stress conditions typical of the tumor microenvironment, whether
hypoxia, shortage of nutrients, protein toxicity or exposure to molecular therapy activate a coordinated set of
cellular responses, a network that sustains cell proliferation, promotes survival, reconfigures metabolism,
stimulates gene expression, and heightens cell motility and invasion. The net effect for the malignant
population is not only improved fitness to cope with an unfavorable microenvironment, but also the acquisition
of new traits characteristic of aggressive disease, including drug-­resistance and metastatic competence.
Unexpectedly, we identified reprogramming of mitochondrial functions as an obligatory hub for this process,
enabling organelle-­cytoskeleton dynamics, assembly of novel apoptosis-­regulatory complex(es), and
retrograde gene expression. Therefore, the hypothesis that tumor plasticity imparts cellular diversity in
response to stress, propagates tumor heterogeneity and promotes the acquisition of aggressive disease traits
through mitochondrial reprogramming can be formulated, and will constitute the focus of the present
application. The proposed studies will dissect the cellular and molecular requirements of tumor plasticity as a
novel hallmark of cancer, credential its relevance in xenograft and genetic mouse models of localized and
metastatic disease, and exploit emerging vulnerabilities of these pathways for innovative cancer drug
discovery. The results will establish tumor plasticity as a novel driver of disease progression, reach a
comprehensive blueprint of the role of mitochondrial homeostasis in cancer, and validate new, actionable
therapeutic targets for patients with late-­stage disease.

Public health relevance
PROJECT NARRATIVE Despite an unprecedented understanding of cancer genes and their pathways, a diagnosis of malignancy still carries significant morbidity and mortality. A fundamental barrier to cancer “cures” is the ability of tumor cells to continuously adapt to their environment and select new traits of aggressive disease, such as sustained cell proliferation, heightened survival and the propensity to metastasize. Over the past decade, our work demonstrated that this process of tumor adaptation, or plasticity is the result of an interconnected network of disparate cellular responses, centered on reprogramming of mitochondrial functions. The studies proposed in the present application will dissect the biology of tumor plasticity as a novel hallmark of cancer and actionable therapeutic target in advanced- stage disease.